Diet and the exposome in autism: Discovering complex interactions with diet in autism etiology and variability

ABSTRACT
Multiple factors contribute to the development of autism spectrum disorder (ASD), a developmental
condition with early onset and heterogeneous phenotype. Prenatal diet is one of the few factors that has
been associated with reductions in risk of ASD, and emerging evidence also suggests certain nutrients may
mitigate the effects of other environmental exposures. At the same time, packaged and highly processed
foods represent a major source of exposure to classes of chemicals linked with adverse neurodevelopment.
The balance of risks and benefits in the diet, and effects on ASD, particularly within the context of other
common risk factors, has not been well studied. The overarching goal of this project is to determine
the role of diet and its complex interactions with other exposures in the development and
presentation of autism spectrum disorder (ASD). This project will use existing data from up to 10,000
mother-child participants from the Environmental influences on Child Health Outcomes (ECHO) consortium,
a large US program initiated with over 60 cohorts following a common protocol to study child health from
gestation to adulthood. We address key gaps in the field under 3 related aims. 1) Examine complex
interactions of prenatal diet and exposure to common chemicals on ASD. We focus on chemical exposures
with diet as a major source and in common use, including pesticides, phthalates, and phenols, to better
understand risks within the diet. We will first examine independent effects of under-studied but highly
consumed “high burden foods” on ASD and related traits, and next use advanced mixture models to capture
interactions between nutrients and measured levels of chemicals, and address potential mitigation of
chemical exposure effects across sources by healthy components of the diet. We will utilize existing
metabolomics data from prenatal measurements, which capture the biological effects of exposures, to
determine pathways that may link these factors to ASD and bolster evidence for mechanisms that underlie
associations. Next, we expand the consideration of the role of diet to: 2). Examine multi-exposure effects
on ASD to determine key players in the prenatal exposome. Building from our prior work in ECHO, we will
examine the ability of prenatal dietary factors to modify the effects of another common exposure rising in
prevalence in the US in parallel with ASD: maternal metabolic conditions during pregnancy (which include
obesity, gestational diabetes, and gestational hypertension). We will then use advanced data science
approaches to determine how the wider set of prenatal risk factors across environmental, medical and
lifestyle factors contributes to the gestational “exposome,” (the entirety of exposures), to influence ASD risk,
and uncover key factors. As in aim 1, these analyses will be followed by mechanistic work using
metabolomics data to determine key pathways underlying identified signals. As secondary outcomes across
Aims 1 and 2, we will examine risk of not just ASD itself, but also its highly co-occurring conditions and
ASD-related traits, to advance understanding of contributors to variability in ASD. Finally, we will make use
of the large numbers in ECHO with information on childhood exposures to: 3). Determine dietary risks and
deficiencies in children with ASD and examine how these contribute to phenotypic variability. These
analyses will determine if autistic children experience worse nutrition than children without ASD, including
higher intake of high burden foods, and assess whether these dietary differences contribute to symptom
severity or risk of comorbidities, accounting for prenatal maternal exposures.
Completion of these aims will aid discovery of novel interactions and exposures whose effects may be
lessened or made worse by different aspects of diet. Ultimately, findings from this project will advance
understanding of the role of diet in ASD and the broader ASD exposome, and present opportunities for
interventions with the potential to reduce risks and improve the lives of autistic individuals.